Applied Curriculum in Gender and Equity Skills (ACES)

JOHNS HOPKINS ACES SUMMARY
The implementation of equitable health programs requires consideration and integration of gender and gender
analysis for such programs to achieve an impact on health outcomes and equity. The Applied Curriculum in
Gender and Equity Skills (ACES) will develop an applied educational curriculum to advance research and
implementation skills for gender analysis and integration in health globally (Aim 1). This curriculum will be
piloted and implemented through an online Accelerated Learning Institute at Johns Hopkins University (JHU)
(Aim 2). Over time, ACES will sustain a community of practice of gender specialists by leveraging existing
external and internal networks (Aim 3).
Building on existing successful courses on gender analysis, women’s leadership, women’s health, and gender-
based violence research methods, the ACES curriculum will be composed of a series of short, intense, online
courses offered through the JHU Bloomberg School of Public Health to provide training in gender and health
equity. Courses will focus on applied methods, including using data to promote gender equity and health,
gender transformative interventions, gender budgeting, conducting gender situational analyses, gender
responsive monitoring and evaluation, and advocacy and communication for gender and health equity. The
curriculum will be grounded in real-world challenges and informed by leading-edge scholarship, with a diverse
faculty of experts in the field and a student body bringing lived experiences to the classroom. We will
incorporate anti-oppressive principles into our teaching and learning to create inclusive spaces that encourage
open participation. ACES will target current and future global public health professionals around the world, both
internal and external to JHU, seeking applied gender skills. We will provide full-tuition scholarships to external
participants, reducing barriers to entry for professional development in applied gender skills and enhancing
participant diversity. The ACES curriculum will strengthen students’ qualifications for obtaining gender
specialist positions in government, non-profits, and academia globally.

Public health relevance
JOHNS HOPKINS ACES NARRATIVE Johns Hopkins Bloomberg School of Public Health will develop an Applied Curriculum in Gender and Equity Skills (ACES) in order to increase skills and competencies in gender and health equity among current and future health professionals. ACES will develop, pilot and implement a series of short, intense, online courses to provide training in gender and health equity to health and development professionals with particular focus on applied methods, including using data to promote gender equity and health, gender transformative interventions, gender budgeting, conducting gender situational analyses, gender responsive monitoring and evaluation, and advocacy and communication for gender and health equity.